Advocacy Skills Trainig for Families Impacted by TBI

[unreadable] DESCRIPTION (provided by applicant): In the United States, there are 3.9 million adults disabled as the result of traumatic brain injury (TBI). These people live with significant and permanent alterations in social, behavioral, physical, and cognitive functioning. If they are to obtain the services that are necessary to address the effects of TBI, families need to be effective advocates. However, the significant impact of brain injury on families leaves them poorly equipped to advocate for services, especially in this era of shrinking availability of rehabilitation options. This Phase I project will develop an interactive multimedia CD-ROM for families affected by TBI, focusing on effective communication skills used to advocate for services to address social behavior in adults with TBI. Phase II development will adapt the CD-ROM materials for Internet use and expand content to include: (a) four additional advocacy skills, (b) additional areas of concern (e.g., physical/medical issues, cognitive functioning, psychosocial concerns, vocational planning, community integration, and substance abuse/misuse), (c) the ability to tailor information by degree of support provided by the family member to the individual with brain injury, and (d) a repeat-visit function. In addition, a web-based chat room will provide social support. [unreadable] [unreadable] [unreadable]